2023 Cell Growth and Proliferation Gordon Research Conference and Seminar

SUMMARY
This proposal is a request for support from the NCI for partial support of the Gordon Research Conference (GRC)
“Cell Growth and Proliferation: Cell Cycle and Proliferation in Development and Cancer.” The conference will
gather 150-200 graduate students, postdoctoral fellows, staff scientists, junior and senior faculty, lab leaders in
industry and government for discussions of their most recent unpublished discoveries. The Conference will focus
on mechanisms of normal cell proliferation control, the many cell cycle variations required for normal growth,
and the variety of abnormal cell cycle perturbations in cancer and other proliferative diseases. The program
format is an approximately equal mix of invited speakers with speakers selected from abstract submitted in the
spring of 2023 with an emphasis on broad representation of speakers from multiple disciplines, career stages,
demographic and geographic backgrounds. The Chair and Vice Chair are specifically committed to creating a
diverse and inclusive conference that reflects the breadth of cell cycle control and fundamental cancer cell
biology research and that showcases the contributions of both junior and senior members of the field; 44% of
the confirmed invited speakers are women and all discussants are women. Topics of formal research sessions
planned include an opening session focused on Protein Degradation in Development and Cancer and additional
sessions including 1) Cell Cycle Machinery and Cell Division, 2) Proliferation and Genome Stability, 3)
Mechanisms of Cell Cycle Progression and Quiescence, 4) Driving the Cell Cycle, 4) Targeting CDKs in Cancer,
5) Signaling Pathways in Development and Cancer, 6) Genome Integrity and Immunity, and 7) System biology
and Genomics. In addition, there will be four poster sessions and ample unstructured time for informal
networking. We will also use funding to partially support the affiliated Gordon Research Seminar (GRS). The
GRS is a 1.5day event that immediately precedes the GRC organized by and for postdocs and students to
present their work and engage in career development. Both events will be held at Mount Snow Resort, West
Dover, Vermont from July 9-14, 2023, and the GRC is a major conference relatively unique in its breadth because
it brings together researchers focused on basic and translational biology from academic and industry settings.

Public health relevance
PROJECT NARRATIVE The Gordon Research Conference “Cell Growth and Proliferation” will bring together a diverse group of investigators to exchange the latest unpublished results and to discuss new ideas. This event will accelerate research into mechanisms of cell proliferation control, ultimately leading to better treatments of diseases and conditions such as cancer, developmental disorders, or/and degeneration.